The role of the (p)ppGpp-mediated stringent response in Clostridioides difficile's resilience to nutrient and immune stresses typically found within a mammalian host

Project Summary/Abstract
Clostridioides difficile infection (CDI) is the most common and costly nosocomial infection in the
United States. The responsible pathogen is an extremely resilient bacterium, tolerant of multiple
classes of antibiotics. As a result, CDI has a very high 20-35% recurrence rate. While the
stringent response (SR) mediated by (pp)pGpp `alarmones' is crucial for survival and virulence
in a number of bacterial pathogens, this had not previously been studied in C. difficile. Our
preliminary research demonstrated that C. difficile utilizes alarmone signaling to coordinate
its response to antibiotic-induced stresses. We further determined that chemical inhibition or
genetic knockdown of a clostridial alarmone synthetase enzyme increases C. difficile antibiotic
susceptibility. Stationary phase onset, acid stress, and oxidative stress were identified as
inducers of alarmone synthesis. Additionally, oxidative stress stimulates C. difficile biofilm
formation, a protective mechanism against stressors. As limited nutrient availability triggers the
(SR) in a number of pathogens, and stimulates sporulation and toxin synthesis in C. difficile, our
hypothesis is that alarmone signaling coordinates clostridial responses to nutrient,
immune, and antibiotic stressors and contributes to the extreme resilience of this
pathogen. We anticipate that the SR will influence motility, biofilm formation, sporulation, and/or
toxin production as well as antibiotic survival. Unexpectedly, we have found that C. difficile was
found to exclusively synthesize pGpp rather than canonical (p)ppGpp alarmones and must
hydrolyze two phosphate bonds for this synthesis. This is without precedent in bacterial species
with characterized SRs. As the challenge of designing therapies against CDI is to balance
lethality and specificity in order to avoid damage to beneficial commensal microbiota, the
divergence of clostridial synthetases from mechanisms conserved in other organisms
presents an attractive target for the design of SR inhibitors specific to C. difficile for
reducing antibiotic survival. The Purcell lab has established a robust research program and
trained several graduate and undergraduate students. We propose exploring the role of nutrient
and stress sensing in regulating C. difficile physiology and behavior within the host while
determining the role of the SR in regulating disease-relevant bacterial processes. Further,
enzymes that mediate alarmone metabolism in C. difficile will be characterized. This proposal
will allow us to expand our training activities in order to involve more students in meaningful
research investigating an unexplored mechanism of C. difficile stress survival with implications
for CDI persistence and recurrence.

Public health relevance
Project Narrative Our preliminary research has determined that pathogenic Clostridioides difficile, which can survive treatment with multiple classes of antibiotics, utilizes the stringent response when confronting antibiotic and immune stress and displays increased antibiotic susceptibility when this signaling pathway is disrupted. We have further demonstrated that, uniquely among bacterial pathogens studied to date, C. difficile utilizes a triphosphate pGpp alarmone rather than the well-characterized ppGpp and pppGpp, requiring the hydrolysis of two phosphate bonds rather than one for each alarmone molecule synthesized. We propose training graduate and undergraduate student researchers to: define the role of pGpp signaling in C. difficile motility, biofilm formation, sporulation, and toxin synthesis stimulated by environmental conditions; identify innate immune stressors that this organism survives by employing pGpp signaling; and fully characterize the unique mechanism of pGpp synthesis in this bacterium to inform future development of stringent response inhibitors, which could specifically sensitize C. difficile to antibiotics without harming beneficial commensal microbes.